Functional Study 16, and Quality Control and Data Collection Support for the Seattle Structural Genomics Center for Infectious Diseases

To determine the solution structure of at least three (3) proteins using Nuclear Magnetic Resonance (NMR)-based methods. These proteins will be targets approved by NIAID for entry into the Seattle Structural Genomics Centers for Infectious Diseases pipeline, from NIAID Category A-C infectious disease organisms, as well as emerging and re-emerging disease. The final set of structures will be deposited in the Protein Data Bank (PDB; http://www.pdb.org) and immediately released to the research community. Will also provide support for screening 36 unknown/putative Mycobacterium proteins using Bioaffinity Mass Spectrometry (BMSS).